International Society for Biomedical Research on Alcoholism (ISBRA)

SUMMARY
The Congress of the International Society for Biomedical Research on Alcoholism (ISBRA) is the premier
international scientific meeting devoted to alcohol research. Alcohol use and misuse is the leading risk factor
for attributable burden of disease among people ages 25 to 49 and the 7th highest risk factor for premature
death and disability worldwide. Given the immense global public health and personal cost of alcohol misuse
and use disorders, it is critical to have a venue for scientific exchange among international researchers to
address important research questions that inform public health policies, prevention and treatment strategies.
The ISBRA Congress brings together an international cadre of alcohol researchers that study the biomedical,
psychosocial, and clinical aspects of alcohol use, misuse and addiction. During this Congress, basic and
clinical scientists provide updates on scientific findings, exchange ideas, discuss and debate issues in the field,
and form scientific collaborations. This scientific exchange is invaluable for both established and developing
research programs around the world. The ISBRA Congress location is rotated among the Americas, Europe,
and Asia/Australia. The 2024 ISBRA Congress will be held on September 23-26 in Melbourne, Australia as a
joint meeting with Asia-Pacific Society for Alcohol and Addiction Research (APSAAR); the 2025 Congress will
be held in June 21-25 as a joint meeting with the Research Society on Alcoholism (RSA) in New Orleans, LA,
USA. Subsequent meeting locations will rotate among Europe, Asia and then the Americas, the destination
determined by the ISBRA Board in accordance with locations acceptable to NIH. This grant would provide
partial travel support for scientists to attend these important Congresses. Funding support is prioritized to
ensure that trainees, early-stage career investigators, and other meritorious scientists are able to attend and
participate in the conference, to foster the growth of young scientists that will develop into the leaders of the
alcohol research field.

Public health relevance
PROJECT NARRATIVE Alcohol use and misuse is the leading global risk factor for attributable burden of disease among young adults. The International Society for Biomedical Research on Alcoholism (ISBRA) is the premier international organization focused on promoting excellence in alcohol research, and ISBRA Congresses provide an important forum for discussion and collaboration among researchers focused on this serious public health problem. This grant provides support for trainees and early-stage investigators to participate in the conference and engage in efforts to address the biomedical, psychosocial, and clinical issues related to alcohol use and misuse.